ONCE DAILY 400MG UNIPHYL TABLETS/QID BECLOVENT INHALATION AEROSOL IN ASTHMA PTS

The purposes of this multicenter trial is to compare the effects of long acting theophylline compounds with that of a steroid aerosol in the control of asthma.